Characterization of degranulation regulators in human mast cells

PROJECT SUMMARY/ABSTRACT
This project’s long-term goals are to understand the regulation of human mast cell (MC) function and to
elucidate the roles of MCs in human health and disease. MCs are major effector cells in IgE-associated
responses (e.g., asthma, allergy, parasite immunity). These cells also may contribute to certain autoimmune
disorders and in the initiation of responses to pathogens and other agents. Upon activation, MCs undergo
degranulation, leading to the secretion of many mediators (including stored products, e.g., histamine, heparin
and proteases), as well as the production of lipid mediators, e.g., LTC4 and PGD2, and many cytokines and
growth factors. Depending on the setting, MCs can have effector and/or immunoregulatory roles. Most
research investigating MC development and function has employed various mouse models. However, we
know considerably less about the mechanisms that regulate the activation of human MCs. Similarly, relatively
little is known about how the perturbation of signaling pathways in human MCs can contribute to MC-
associated pathology. This, in turn, has hampered the design of therapeutic agents for the treatment and/or
prevention of allergies and other mast cell-associated diseases in human subjects. We recently developed a
technology platform employing functional genomics, coupled with high-resolution single-cell confocal imaging,
which can rapidly identify regulators of degranulation in human mast cells. We now propose to use this
platform to identify key regulators of IgE/FceRI-dependent signal transduction pathways in cultured, donor-
derived, primary human mast cells. Specifically, we will attempt to validate, in primary human mast cells,
selected major degranulation regulators previously identified in rodent mast cells. We also will use targeted
arrayed human CRISPR-Cas9 libraries to identify novel (i.e., previously unidentified) regulators of IgE/FceRI-
dependent signaling pathways in primary human mast cells. In addition, we will investigate the functional
significance of the KIT D816V mutation detected in mastocytosis patients by using the CRISPR-Cas9-based
gene editing technologies to induce/correct the same mutation in human HMC-1 cell lines and primary human
mast cells. To achieve our goals, we propose two aims. In Aim 1, we will identify novel human mast cell
degranulation regulators and systematically define IgE/FceRI-dependent signaling pathways in primary
human mast cells. In Aim 2, we will use CRISPR-Cas9 “prime editing” to perform mutational studies of HMC-
1 human mast cell lines and primary human mast cells. Together, this work will help create a detailed model
of mast cell degranulation in human mast cells and will begin to analyze how the KIT D816V mutation may
influence human mast cell biology.

Public health relevance
PROJECT NARRATIVE Each year, more than 50 million Americans experience various allergic diseases, including asthma, hay fever, atopic dermatitis (“eczema”) and food allergies, that together impose huge burdens of suffering, time lost from school and work, and healthcare delivery costs. Mast cells are known to contribute significantly to these diseases, since mast cells can be activated by allergens to release highly potent inflammatory mediators. By elucidating the regulatory mechanisms mediating such human mast cell activation, this project may permit the discovery of new therapeutic approaches for reducing the health and economic burdens of allergic diseases.